Cortical Mechanisms of Visual Category Recognition and Learning

Summary and Relevance of Proposed Research
Humans have an impressive capacity to recognize the category membership of sensory stimuli. This ability,
which is disrupted by a brain-based diseases and conditions such as Alzheimer’s disease, schizophrenia,
stroke, and attention deficit disorder, is critical because it allows us to respond appropriately to stimuli and
events that we encounter in the environment. We are not born with an innate library of categories which we are
preprogrammed to recognize. Instead, we learn about familiar categories through experience. Our work
showed that the posterior parietal cortex (PPC) and prefrontal cortex (PFC) are involved in categorical
decisions. We recorded from neurons in PPC and PFC during visual motion categorization tasks, revealing that
neurons in both areas robustly encode stimuli according to their learned category membership. This shows that
both regions are involved in representing abstract visual categorical information. We also showed that activity
in PPC is causally related to categorical decisions, using reversible inactivation. This project uses novel
recording techniques to monitor activity of large neural populations in the lateral intraparietal area, frontal eye
field, and superior colliculus during categorical decisions. This will yield a mechanistic understanding of how
interactions between these three regions enable computations which underlie categorical decisions. This work
will also determine how multiple behavioral functions are mediated by this brain network, including eye
movements and attention, as well assess the causal significance of each brain area to categorical decisions.
While much is known about how the brain processes visual features (such as color, orientation, and direction
of motion), less is known about how the brain learns and represents the meaning, or category, of stimuli. A
greater understanding of visual categorization is critical for addressing a number of brain diseases and
conditions (e.g. stroke, Alzheimer’s disease, attention deficit disorder, schizophrenia, and stroke) that leave
patients impaired in everyday tasks that require visual learning, recognition and/or evaluating and responding
appropriately to sensory information. The long-term goal of this project is to guide the next generation of
treatments for these brain-based diseases and disorders by helping to develop a detailed understanding of the
brain mechanisms that underlie learning, memory and recognition. These studies also have relevance for
understanding and addressing learning disabilities, such as attention deficit disorder and dyslexia, which affect
a substantial fraction of school age children and young adults. Thus, a detailed understanding of the basic
brain mechanisms of categorical decisions and attention will likely give important insights into the causes and
potential treatments for disorders involving these cognitive and perceptual abilities.

Public health relevance
Project Narrative Our ability to recognize the category, or behavioral significance, of visual stimuli is essential for planning and carrying out successful behaviors in response to our surroundings. The goal of this research project is to provide a detailed and mechanistic understanding about how the brain learns and recognizes visual categories. A detailed understanding of these brain mechanisms is critical for understanding and ultimately addressing the profound deficits of learning, memory and visual recognition that frequently accompany brain diseases and conditions such as stroke, schizophrenia and Alzheimer’s disease.